Nanoelectrochemical Techniques for Single Cell and Spheroid Metabolomics and Pharmacokinetics

Tissue is extraordinarily complex, and new measurement tools are necessary to elucidate
cellular function and composition at never-before-observed levels. The long-term goal of this
research program is to develop nanoelectrochemical technologies for single cell and spheroid
function and composition. The main focus will be on metabolomics (quantifying several
metabolites simultaneously) and pharmacokinetics (quantifying analyte concentrations with
time). We endeavor to make the most accurate measurements of cellular metabolites with sub-
micrometer resolution while minimally perturbing cellular homeostasis. These measurements
have the potential to open the door to unrealized sensitivity in sub-cellular metabolite
quantification. Electrochemistry at nanoelectrodes has been used to interrogate cellular
processes and quantify reactive species within cells. However, the amount of charge required to
make an electrochemical determination can be detrimental to a cell, which comprises a rather
small volume, within 100 milliseconds. Therefore, novel techniques must be developed to
minimize the perturbation to cellular homeostasis to ensure accurate measurements of natural
cellular processes. To achieve low-charge electroanalysis, our group has innovated novel
potentiometric and aptamer-based sensing modalities. Over the next five years, metabolite-
specific sensors will be miniaturized to the sub-micrometer scale for single cell and spheroid
analyses. Multibarrel nanoelectrodes will be developed and optimized to quantify several
metabolites in single cells and spheroids with high spatiotemporal resolution. These sensors will
be deployed into single cells and spheroids for metabolomics and pharmacokinetics studies.
Findings will be validated with microscopy and mass spectrometry. Finally, the sensing
modalities will be extended to build onto a new bioimaging platform: the Hyperspectral-Assisted
Scanning Electrochemical Microscope, a low-cost alternative to white light laser confocal
microscopy. The overarching goal of this research program is to create the foundation for
generalized metabolomics studies with nanoelectrode sensors, where the library of metabolites
of interest depends only on the availability of an enzyme or a carefully designed aptamer.

Public health relevance
A detailed understanding of human disease at the single cell level represents a challenging frontier, and very few measurement techniques are available to accurately probe cellular composition and function with unprecedented spatiotemporal resolution. This MIRA application draws from our experience with nanoelectrochemistry, sensor development, and single cell and spheroid analysis to innovate a generalizable nanoelectrochemical measurement platform for single cell and spheroid metabolomics and pharmacokinetics. We will accomplish this through innovative nanoprobe design, giving rise to powerful bioimaging platforms to probe composition and function while minimizing perturbation to cellular homeostasis.